ADVANCING CLINICAL PRACTICE AND ESTABLISHING FOUNDATIONAL THEORY FOR AUDITORY FUNCTION IN INDIVIDUALS WITH DOWN SYNDROME

PROJECT SUMMARY/ABSTRACT
Up to 80% of individuals with Down syndrome have hearing loss across the lifespan, including fluctuating
conductive hearing loss and permanent sensorineural hearing loss. Early onset presbycusis is also observed for
this population, consistent with precocious aging observed in other domains. However, most existing prevalence
data were obtained from medical record review or assessment of individuals living in institutions complicating
application to individuals with Down syndrome in the general population. Individuals with Down syndrome have
structural differences in cranial anatomy compared to neurotypical individuals, including that which would predict
high rates of hearing loss and otitis media with effusion (OME). However, these factors can also impact stimulus
presentation level. Specifically, stenotic ear canals and OME both result in increased stimulus levels; hearing
loss may be underestimated if these factors are not considered during stimulus calibration or presentation.
Critically, this issue may have contributed to previous findings of shortened auditory brainstem response (ABR)
waveform latency for individuals with Down syndrome relative to age-matched neurotypical peers, a metric useful
for clinical diagnosis of conductive hearing loss in individuals for whom a reliable behavioral response to sound
is unable to be obtained. AIM 1 defines the prevalence, type, and trajectory of hearing loss for individuals with
Down syndrome in the general population. Significant innovation to clinical audiology is gained using rigorous
calibration techniques, which will resolve the issue of ABR latency and provide comprehensive data on peripheral
sensitivity across the lifespan. Just as for neurotypical populations, hearing loss puts individuals with Down
syndrome at risk for major challenges to communication, learning, socialization, and employment opportunities.
Specifically, sensorineural hearing loss results in broad auditory filter bandwidths limiting accurate identification
of speech sounds. Low cerebellar and cortical volumes observed in individuals with Down syndrome are
associated with temporal processing difficulties across domains and may impact the saliency of brief
improvements in signal-to-noise ratio when listening in background noise. Whereas cognition and language
contribute to successful masked speech recognition in neurotypical populations, high rates of language
difficulties and intellectual disability are likely to undermine functional hearing abilities for individuals with Down
syndrome. AIM 2 establishes foundational theory regarding the functional auditory abilities of individuals with
Down syndrome guided by a model of masked speech perception that includes audibility, psychophysical
measures of spectral and temporal resolution, and neuropsychological factors of selective attention, working
memory, and vocabulary knowledge.

Public health relevance
PROJECT NARRATIVE The immediate goals of this application are to improve audiologic clinical assessment of individuals with Down syndrome across the lifespan and advance scientific theory in the study of functional hearing abilities in this population. Long-term improvements to public health are anticipated as auditory difficulties are identified and alleviated for individuals with Down syndrome allowing for successful participation in social, educational, and employment opportunities to the fullest extent.